Clinical Outcomes and the HCV Core Gene

DESCRIPTION (provided by applicant): End stage liver disease and liver cancer are major health concerns for individuals with hepatitis C virus (HCV) infection. Current therapies for HCV aim to halt and reverse the progression of liver injury. These therapies are based on interferon (IFN) and are expected to continue to be based on IFN for the foreseeable future. Both host and viral factors influence treatment outcome. Published data show that viral point mutations in the core gene are associated with treatment failure and insulin resistance. Of great interest, these same mutations (in codons 70 and 91) are associated with the development of liver cancer. These highly specific viral point mutations provide a unique opportunity to investigate HCV-related liver damage and treatment failure at the molecular level. We recently discovered that the disease-associated mutations in codons 70 and 91 have a profound effect on HCV gene expression: They alter the level of two newly identified viral proteins, 70 minicore protein and 91 minicore protein. In a major finding, we discovered that the disease-associated mutation in codon 91 enhances the internal initiation of protein synthesis at codon 91. Our data add to earlier evidence that HCV uses divergent modes of translation initiation to evade cellular antiviral defenses and to increase viral fitness. To account for minicore production, we propose that the core gene contains an extensive and highly conserved translational machine that promotes the internal initiation of protein synthesis at specific sites, driving minicore synthesis and enhancing IFN resistance and viral persistence. The impact of mutations in codons 70 and 91 on the IFN sensitivity of viruses and on the structure and function of minicore proteins will be investigated in Aim I. The properties of the translational machine and the effect of the disease-associated mutations on its activity will be determined in Aim II. Accomplishment of our Aims will fill fundamental gaps in the understanding of the HCV life cycle and provide basic information needed to design interventions to block the action of the translational machine and to inhibit the effects of the minicore proteins in patients.

Public health relevance
PUBLIC HEALTH RELEVANCE: Clinical studies of liver disease patients with chronic hepatitis C virus (HCV) infection provide vital information about viral and host determinants of treatment outcome and disease progression. It is thus highly significant that clinical studies have identified two mutations in HCV that are strongly associated with treatment failure and the development of liver cancer. This project investigates the action of these mutations at the molecular level, with the ultimate goal of developing interventions to block the effects of the viral genes influenced by the disease- associated mutations. Clinical studies of liver disease patients with chronic hepatitis C virus (HCV) infection provide vital information about viral and host determinants of treatment outcome and disease progression. It is thus highly significant that clinical studies have identified two mutations in HCV that are strongly associated with treatment failure and the development of liver cancer. This project investigates the action of these mutations at the molecular level, with the ultimate goal of developing interventions to block the effects of the viral genes influenced by the disease- associated mutations. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Overall objective: To determine the impact of clinically-significant mutations in codons 70 and 91 of the HCV core gene on HCV protein synthesis, IFN resistance, persistence, and cellular antiviral responses. Hepatitis C virus (HCV) is the most common cause of blood borne infection in the U.S. (2). The serious liver damage and liver cancer caused by HCV are largely due to its unusual ability to establish persistent infection. There is no HCV vaccine. Current therapies are based on interferon (IFN) and ribavirin. Rates of sustained virological response vary depending on both host (3-5) and viral factors (6-8). Because IFN is expected to re- main an essential component of HCV treatment for the foreseeable future (9; 10), overcoming IFN resistance is a priority for both basic and clinical research. Mutations in codons 70 and 91 of the genotype 1b HCV core gene provide a valuable focus for this research because they predict IFN treatment failure (11-20) and other adverse outcomes including the development of liver cancer (21-25). Because these mutations are important determinants of clinical outcome, they provide a unique opportunity to investigate the molecular basis of HCV pathogenesis, IFN treatment failure, and persistence. The value of these mutations as research tools was re- cently confirmed by the demonstration that they confer IFN-resistance when introduced into infectious HCV in a cell culture model (26). We gained a key insight into the mechanism of action of the disease- associated mutations when we discovered that the mutations in codons Core Gene 70 and 91 dramatically alter the levels of two novel HCV proteins, 70 minicore and 91 minicore (Fig. 1). 70 and 91 minicores are members of a 70 Minicore newly identified family of proteins that contain the C-terminal portion of the classical p21 core protein, but lack the N-terminal portion (1). Mini- 91 Minicore Protein cores escaped detection until 2009 because they can only be detected Fig. 1. The core gene drives production with antibodies that recognize the C-terminal portion of the core protein, of minicore proteins with N-termini at whereas the vast majority of anti-core antibodies bind the (highly anti- codons 70 and 91 genic) N-terminus. In experiments whose results challenge current paradigms of HCV protein synthesis, we determined that the disease-associated mutation in codon 91 enhances internal initiation at codon 91, in- creasing production of 91 minicore (1). Our studies uncovered additional sites of internal initiation downstream of the canonical AUG start site at codon 1. To account for our findings, we propose that the core gene con- tains an extensive, highly conserved translational machine that promotes the internal initiation of protein syn- thesis at specific sites, driving minicore synthesis and enhancing IFN resistance and persistence. We further postulate that the need to maintain this machine is the evolutionary constraint that is responsible for the previ- ously unexplained conservation of the core gene (27-29). If this hypothesis is correct, it means that HCV has committed a significant portion of its relatively small genome to the minicore translational machine, emphasiz- ing its importance to viral fitness. The impact of mutations in codons 70 and 91 on the IFN sensitivity of vi- ruses and on the structure and function of minicore proteins will be investigated in Aim I. The properties of the translational machine and the effect of the disease-associated mutations on its activity will be determined in Aim II. Accomplishment of our Aims will fill fundamental gaps in the understanding of the HCV life cycle and provide the information needed to design interventions to block the action of the translational machine and to inhibit the effects of the minicore proteins in patients. Specific Aim I. Hypothesis: Minicores and the clinically-significant mutations in codons 70 and 91 contribute to IFN resistance and to the ability of HCV to withstand cellular antiviral defenses. The experimental goals are: 1: To directly determine the impact of the disease-associated mutations in codons 70 and 91 on the ability of infectious HCV to survive IFN treatment and arsenite-induced cellular stress by monitoring viral RNA kinetics and viral protein patterns by qRT/PCR and Western blotting. 2: To test the ability of transgenic (codon-optimized) minicore proteins to block the antiviral effects of IFN and alter the type I IFN response pathway using IFN-sensitive reporter viruses and human mRNA microarrays. Specific Aim II. Hypothesis: The HCV core gene harbors a key translational machine that mediates the inter- nal initiation of protein synthesis, promoting minicore synthesis and persistence. The experimental goals are: 1: To define the initiation codons and the translational signals that drive minicore expression, using mutagene- sis, ribosome protection, translation inhibitors, RNA structural probing, and RNA model building; 2: To identify the mechanism of ribosome recruitment and to test for a novel HCV IRES located within the core gene using dual-luciferase reporter assays and circular RNA transcripts (which lack free ends and thus provide a direct test for ribosome recruitment to internal regions of RNA molecules). 70 91